Parental Responses to Children’s Negative Emotions: Impact on Neural and Physiological Self-Regulation

PROJECT SUMMARY
Effective emotion regulation (ER) is essential for successful development, as difficulties in ER are associated
with significant emotional, behavioral, and mental problems. Early in life, parental responses to their child’s
negative emotions play a significant role in the development of adaptive ER. However, little work has explored
how in-the-moment parental responses during in-vivo emotional events influence children’s ER. Furthermore,
while the functioning of biological systems is crucial in shaping the development of effective emotional
processes, there is a significant gap in understanding how in-the-moment parental responses influence
children’s neural and physiological regulation. Aligning with NICHD’s Strategic Objective 4 which focuses on
“improving child and adolescent health and the transition to adulthood”, this K99/R00 proposal aims to explore
how in-the-moment parental responses influence key neural and physiological markers of ER, especially in
response to negative emotions (Aims 1, 3, and 4). Additionally, the quality of the parent-child relationship is
hypothesized to play a crucial role in moderating the effects of the relationship between parental responses
and children’s neural and physiological regulation. Therefore, the proposed study will also examine how
parent-child relationship quality influences the association between parental responses and the child’s neural
and physiological ER (Aims 2, 5). This research will employ EEG and ECG measures (i.e., alpha asymmetry,
respiratory sinus arrhythmia) to assess children’s neural and physiological ER processes. Observational
assessments of parental responses will also be conducted to capture dynamic parent-child interactions. The
findings from this project could significantly improve our understanding of how in-the-moment parenting affects
child ER by integrating neural and physiological data, offering insights that may inform future intervention
strategies. The K99/R00 phase of the award will provide essential training in four key areas: 1) EEG and ECG
methodologies; 2) behavioral coding of parental responses to children’s negative emotions; 3) longitudinal
study design, data collection, and analysis; 4) theoretical and methodological approaches to studying the
impact of parent-child relationship quality on child ER. A multidisciplinary team of mentors and consultants has
been assembled to support the candidate in achieving these training objectives. Ultimately, this research will
offer new insights into the dynamic relationship between parenting and children’s neural and physiological
regulation during early to middle childhood, a period when ER transitions from being primarily externally
regulated by parents to becoming more internally regulated by the child. The proposed research and training
plan will prepare the candidate to establish an independent and distinctive research program that employs
multi-modal methods to advance the field of developmental psychology, with the long-term goal of informing
evidence-based strategies that promote healthy emotional development in children.

Public health relevance
PROJECT NARRATIVE This K99/R00 aims to deepen our understanding of how parental responses to children’s negative emotions influence critical neural and physiological markers of emotion regulation making it highly relevant to public health. By identifying early, modifiable factors that shape the development of self-regulation, this research has the potential to inform targeted, evidence-based interventions that promote adaptive self- regulation, thereby fostering healthy emotional and behavioral development and reducing the risk of mental health disorders later in life. In the long term, the findings could refine parenting strategies, improve child well- being, foster resilience, and significantly reduce the societal and economic impact of mental health challenges by addressing developmental outcomes at this crucial stage of development.